REGULATION OF CELLULAR INORGANIC PHOSPHATE IN PROXIMAL RENAL TUBULES

Inorganic cellular phosphate (Pi) has been difficult to measure accurately in the renal proximal tubule due to methodologic inaccuracy and high rates of Pi transport. A perfusion 31P-NMR probe has been specifically designed to address the inter-relationship between modulators of Pi transport and metabolism and free cellular Pi in these cells. Sensitivity of the perfusion 31P probe enables minute-to-minute monitoring of the cellular pool of Pi with extra-and intra-cellular modulators of metabolism and transport.